Understanding how transposons generate new immune gene protein-coding splice variants

Project Summary
Transposons are ubiquitous genomic elements that can mobilize, replicate, and integrate within the host
genome. Extensive research has focused on how transposons impact their host, revealing instances of both
deleterious and selectively advantageous roles. While transposon exonization (defined as the inclusion of
transposon-derived exons into cellular transcripts through alternative splicing) is common, the biological
relevance of transposon-derived transcript isoforms remains unclear and controversial. Here, I propose to
investigate transposon exonization in coding regions as an important, recurrent evolutionary mechanism that
drives adaptive proteome diversification, specifically in the context of host-pathogen arms races.
In preliminary studies, I re-analyzed long-read transcriptome data from human macrophages and
discovered hundreds of poorly characterized isoforms derived from transposon exonization events for genes
involved in immune and inflammatory responses. These include a transposon-derived isoform of the type I
interferon receptor subunit 2 gene (IFNAR2), which I have experimentally shown to act as a novel immune decoy
receptor. I will use alternative splicing of the IFNAR2 gene as a model to reconstruct the genomic events that
can lead to the successful exonization of transposons to form functional protein isoforms (Aim 1), with the goal
of reconstructing the genetic basis of the “road to co-option” of exonized transposons. Using IFNAR2 as a model,
I will then investigate which mechanisms and factors are involved in the regulation of alternative splicing and
expression of transcribed transposon-derived coding alternative exons (Aim 2). Finally, I will compare long-read
RNA sequencing de novo transcriptome assemblies from multiple species of the vertebrate tree of life to evaluate
the incidence of proteins that evolved through the inclusion of transposons in coding sequences (Aim 3). Taken
together, these aims will establish an experimental framework to test the role of transposable elements in
adaptive proteome diversification, and shed light on the process of how transposons can evolve novel functions
beneficial for their host (transposon co-option) through their inclusion in coding regions. Additionally, they will
provide me with new training in: 1) techniques for testing and validating mechanisms of mRNA and alternative
splicing regulation; 2) how to design and perform immunological assays, including viral infections; and 3) the
execution and troubleshooting of genome-scale screens for phenotypes of interest and training in primary cell
culture and genome engineering. Additionally, I will learn how to perform high throughput long-read RNA
sequencing and isoform-specific transcriptome assembly for model and non-model species. The research and
training provided by this proposal will prepare me to launch my own research group studying how transposon
co-option shapes the evolution of vertebrate proteomes.

Public health relevance
Project Narrative More than 80% of human protein coding genes are alternatively spliced, effectively increasing the proteome in comparison to the total number of genes. While transposable elements have been largely recognized to provide alternative promoters and enhancers, their contribution to the protein coding sequences is still debated. The goal of this proposal is to understand how transposable elements shape the evolution and diversification of vertebrate proteomes, as well as which events and mechanisms promote their origin and affect their expression.